Folding and Chaperone Interactions of Multi-domain Proteins

Project Summary
Combining several functional units, termed domains, into a single polypeptide chain is a common
evolutionary strategy for creating biological complexity. The resulting multi-domain proteins are
prevalent in all proteomes and carry out essential cellular functions. However, the increased functional
complexity of these large proteins complicates their folding into native functional structures. In contrast
to many smaller proteins or individual domains, multi-domain proteins are prone to misfolding and
potentially cytotoxic aggregation. In the cell, several factors ensure efficient folding. Folding begins co-
translationally, while the ribosome still synthesizes the polypeptide. Molecular chaperones begin to
interact with the nascent multi-domain protein as soon as it emerges from the ribosome. Co-
translational folding and chaperone interactions are recognized as crucial for efficient multi-domain
protein folding. However, these processes remain poorly defined at the molecular level, because it is
technically challenging to study them. The goal of this project is to define principles of co-translational
folding and chaperone function to better understand how complex multi-domain proteins robustly reach
their functional structures. We are using a combination of single-molecule biophysics and live-cell
experiments to accomplish this goal. With optical tweezers, we are studying the folding pathways of
nascent multi-domain proteins at the single-molecule level. Manipulation of individual molecules is
ideally suited to resolve complex folding pathways of nascent proteins, elucidate the contributions of
the ribosome and molecular chaperones to the folding process, and determine how co-translational
folding and protein synthesis are coupled and regulated to ensure robust outcomes. These detailed in
vitro studies are complemented by experiments in live cells that detect co-translational folding events
in multi-domain proteins. Protein misfolding and aggregation, misregulation of protein synthesis and
decline of chaperone function are hallmarks of many aging-related diseases. Our studies may ultimately
provide a mechanistic basis for discovering novel therapeutic strategies to treat some of these
diseases.

Public health relevance
Project Narrative Proteins are long chains that must fold into specific three-dimensional structures to carry out their functions, which include digesting nutrients, making muscles contract, and enabling communication of neurons in the brain, among many others. Like long strands of yarn quickly become entangled if not organized into balls, proteins that fail to fold into their functional structures promptly tend to clump together into aggregates, which can be detrimental to cellular and organismal function and is associated with neurodegenerative diseases, including Alzheimer's and Parkinson's diseases. Our mechanistic studies will clarify how proteins fold into their functional structures and avoid aggregation, providing fundamental insights into disease mechanisms.